Decoding and harnessing microbial tuning of T cell responses in early life

Project Summary/Abstract Trillions of microbes reside in and on our body's barrier surfaces. To maintain health our immune system must establish tolerance to these commensal microbes but also preserve the ability to mount protective responses against infectious threats. We have found that adaptive immune tolerance is established to skin commensal bacteria but not skin pathogens and that these divergent responses are established upon first encounter with these microbes early in life. The overarching goal of this proposal is to elucidate the host-directed and microbe-directed mechanisms that support adaptive immune tolerance to commensal microbes while permitting protective immunity to pathogens, using skin as the tissue of focus. To achieve this we will employ cutting-edge immunological and microbiological techniques, including in vivo tools to dissect the antigen-specific response to skin bacteria, a new CRISPRi system to genetically modify skin bacteria and identify key microbial molecules, and a novel pre-clinical platform to examine the impact of microbial products on a human inflammatory skin disease. Ultimately, this high-risk high-reward proposal seeks to inform our understanding of fundamental mechanisms that shape our early `decisions' about tolerance vs. immunity to foreign antigens and identify new therapeutic approaches to modulate these responses for clinical benefit.

Public health relevance
Project Narrative Our encounters with microbes fundamentally shape healthy development of our adaptive immune system but, in certain circumstances, can also contribute to a wide array of inflammatory disorders. The overall goal of this grant application is to understand how our immune system establishes a privileged relationship with commensals while maintaining effective defense against pathogens, employing skin as the tissue of focus. Using this knowledge we hope to identify targeted strategies to modulate these responses for treatment of inflammatory skin disease.